Human iPSC-derived atrial cardiomyocytes to model atrial fibrillation in a dish

Project Summary
Atrial fibrillation (AF) is associated with significant morbidity and increased mortality. Despite recent advances
in catheter-based treatments, antiarrhythmic drugs (AADs) are still commonly used to treat AF. However,
response to membrane-active drugs is highly variable, in part, because of the failure to target therapy to the
underlying mechanisms. Although genetic approaches have provided important insights into the underlying
mechanisms of AF, the translation of these discoveries to the bedside care of patients has been limited due to
the challenges of adequately recapitulating human AF in cellular models. The ability to derive patient-specific
atrial cardiomyocytes (CMs) from human induced pluripotent stem cells (iPSC)-CMs holds great promise for
modeling AF-linked mutations and developing cellular models of AF that are genetically-matched to specific
patients. However, atrial iPSC-CMs have not been used to elucidate the underlying cellular mechanisms of AF-
linked mutations and model heritable AF. Specific Aim 1 will create the UIC Multi-Ethnic Atrial HiPSC-CM
Biorepository with the goal of generating atrial iPSC-CMs from familial AF kindreds to model AF-linked
mutations. Our pilot data shows that atrial iPSC-CMs recapitulated the electrophysiologic (EP) phenotype of an
AF-linked SCN5A mutation, and served as a platform for targeting the underlying cellular mechanism of the
gain-of-function variant. Nonetheless, enhancing the maturity of iPSC-CMs remains important as modeling
mature CMs will not only provide additional insights into the underlying cellular mechanisms of AF but also
identify molecular signaling pathways important for atrial development. Specific Aim 2 will test the hypothesis
that the EP and structural maturity of atrial iPSC-CMs can be significantly enhanced by precise
microenvironmental engineering of in-vivo relevant cell-cell, cell-extracellular matrix, and cell-soluble factor
interactions, such that these cells allow for optimal modeling of AF. We will also assess the role of cardiac
fibroblasts in the pathogenesis of AF and determine if they impact EP maturity by co-culturing them with atrial
iPSC-CMs. Specific Aim 3 will elucidate the underlying cellular mechanisms of AF-linked mutations using
atrial iPSC-CMs. We will determine the EP phenotype of an SCN5A-E428K and KCNQ1-IAP54-56 mutation
using patient-specific atrial iPSC-CMs. In addition, atrial iPSC-CMs from the 2 kindreds will be genetically
corrected using CRISPR-Cas9 system to definitively establish causality. Thus, the overarching goals of this
proposal are to harness the complementary skills of both Co-PIs (Drs. Darbar and Khetani) to establish the
UIC Multi-Ethnic Atrial HiPSC Biorepository to serve as a platform for modeling AF-linked mutations, elucidate
the underlying cellular mechanisms, and identify and assess novel mechanism-based therapies for AF. This
platform will not only enable a more mechanism-based approach to the treatment of AF but will also
`personalize' therapy with improved efficacy and reduced toxicities for individual patients.

Public health relevance
Project Narrative Atrial fibrillation (AF), the most common sustained cardiac arrhythmia worldwide, is associated with increased risk for stroke, heart failure, and death. Although genetic approaches to AF have provided us with important insights into the underlying mechanisms, the impact of these discoveries when it comes to the treatment of AF in individual patients has been limited in part because of lack of appropriate models of AF. Here, we propose to translate these discoveries to the clinical care of patients by modeling mutations linked with AF using atrial induced pluripotent stem cells derived from kindreds with familial AF in order to better understand the underlying mechanisms and uncover new treatments for this common and morbid condition.